Application of Novel Biomarkers of Renal Health in Cirrhosis Patients to Stratify Risk of Acute Kidney Injury Occurrence and Reversibility

PROJECT SUMMARY/ABSTRACT
Cirrhosis is a leading cause of morbidity and mortality among adults in the United States. Acute kidney injury
(AKI) is a common, expensive, and lethal complication of cirrhosis. The strongest predictor of AKI in cirrhosis
patients, regardless of etiology, is chronic kidney disease (CKD), as measured by estimated glomerular
filtration rate (eGFR). Given that there is a rising incidence of both AKI and CKD in this population, there is a
developing critical need for clinical tools that identify cirrhosis patients at risk for AKI before its development.
This proposal’s three research aims address this need. Leveraging an ongoing cohort with >1000
decompensated cirrhosis patients with >2500 banked biospecimens, these aims will: (1) establish the
independent association between renal health biomarkers and AKI and compare the discrimination of novel
renal health biomarkers to serum creatinine (sCr) to predict AKI (Aim 1); develop and internally validate a
clinical risk tool to identify cirrhosis patients most vulnerable to AKI (Aim 2); explore the association between
longitudinal changes in renal health biomarkers on AKI reversibility (Aim 3).
I am a hepatologist specializing in liver transplantation at the University of California, San Francisco. Through a
pilot award provided by the American Association for the Study of Liver Disease, we have generated the
preliminary data needed for this application. These data, coupled with a strong foundation of hepatology and
nephrology research (Master of Advanced Studies in Clinical Research, >10 publications), have prepared me
for this proposal. However, there are several gaps in my training that this NIDDK K23 Career Development
Award will address (e.g., cohort development, advanced statistical techniques). Under the direct supervision of
a multidisciplinary team of leaders in nephrology (Hsu, Liu), hepatology (Lai), and biostatistics (McCulloch), I
will execute a detailed career development plan to accelerate my path toward 4 career goals outlined in this
proposal: (1) to develop a foundation of core nephrological principles; (2) to acquire analytic skills to validate
biomarker use; (3) to learn novel methodologies at risk prediction, including machine learning techniques; (4)
to expand a cohort and to apply methods of longitudinal data analysis. As part of my 5-year plan, I will actively
engage in coursework and structured tutorials in nephrology and biostatistics, and interdisciplinary
development and leadership programs. In addition, I will integrate myself into the nephrology research
community and establish a network of nephrology researchers for current and future collaboration.
RELEVANCE: Identifying a metric that captures which cirrhosis patients are at greatest risk for and least likely
to reverse from AKI has important clinical implications—it will allow for the implementation of interventions that
prevent the occurrence and halt the progression of a major driver of mortality in this population.

Public health relevance
PROJECT NARRATIVE The burden of kidney dysfunction in cirrhosis patients continues to increase; however, the tools we employ to identify a patient’s risk for acute kidney injury are limited. This proposal—through the use of a large longitudinal cohort and novel biomarkers—aims to earlier identify cirrhosis patients at risk for AKI in an effort to implement preventative strategies and reduce kidney-related morbidity and mortality.